Identification of new therapeutic targets for ADPKD

Autosomal-dominant polycystic kidney disease (ADPKD) affects more than 12 million people worldwide and is
a common cause of end-stage kidney disease (ESKD). ADPKD is caused by mutations in one of two genes,
PKD1 or PKD2, which encodes polycystin 1 (PC) and PC2 respectively. Loss of PC1 or PC2 results in
activation of numerous kinases and downstream signaling pathways, which is central to the pathogenesis of
cyst growth in ADPKD. In addition, pharmacologically inhibiting a number of different kinases up-regulated in
PKD kidneys has been shown to slow cyst growth in animal models of PKD making kinase inhibitors among
the most promising class of drug candidates to treat patients with ADPKD. However, while the human kinome
consists of more than 500 kinases, only a fraction of these kinases have been tested to determine if they play a
role in ADPKD pathogenesis. As a result, there are likely many kinases that are active in ADPKD kidneys that
play prominent roles in cyst growth that are yet-to-be discovered and may be good therapeutic targets.
In collaboration with James Duncan at Temple University, we have now adapted a novel approach to
broadly screen PKD kidneys in an unbiased manner for kinases that are more active in lysates from
PKD kidneys compared with lysates from wild type kidneys. In this assay, active kinases are affinity
captured by passing lysates over multiplex inhibitor beads (MIB) containing a cocktail of kinase inhibitors.
Bound kinases are then identified by LC separation followed by quantitative tandem mass spectrometry (LC-
MS/MS). Using this approach, we have now identified a number of both known and unknown kinases
specifically up-regulated and down-regulated in PKD kidneys.
The major goal of this proposal is to assess the role of several of the kinases identified thus far whose activity
is increased in PKD kidneys and determine whether inhibiting or activating any of the kinases identified slows
cyst growth, inhibits interstitial fibrosis, and preserves renal function in animal models of ADPKD. We will then
take both biased and unbiased approaches to identify the signaling pathways regulated by these kinases that
are critical to pathogenesis with the goal of developing a more complete picture of the relevant signaling hubs
and networks that are aberrantly activated in PKD kidneys. In addition, we will use this technology to broadly
screen PKD kidneys from a variety of different “early” and “late” mouse models of ADPKD at different stages in
cyst formation and in kidneys from human patients with ADPKD to identify in an unbiased manner additional
kinases that are activated and inhibited in PKD kidneys to determine the similarities and differences between
mouse models, which kinases may be most relevant to human disease, and whether distinct sets of kinases
are activated early post cyst induction and function as early “drivers” of cyst growth. Ultimately, we hope this
new information will identify new safe drug targets and rational approaches to combination therapies to slow
cyst growth that can then be translated into clinical trials.

Public health relevance
Tolvaptan, which has limited efficacy and significant toxicity, is the only approved treatment that slows the decline of renal function in patients with ADPKD in the US. Among the most promising drug candidates are protein and lipid kinases. We applied a new strategy to identify novel kinases up-regulated in PKD kidneys and will determine whether inhibiting or activating any of these kinases slows cyst growth and progression of kidney disease with the goal to identify new kinases that are potential targets to slow cyst growth in patients.